Putting Telehealth to the Test: An Evaluation of the Use of Telehealth to Increase the Population-Level Impact of an Employer-Based Diabetes Prevention Program

PROJECT SUMMARY
Recent reports of type 2 diabetes (T2DM) as a post-acute sequela of SARS-CoV-2 infection (PASC, clinical
findings lasting beyond 30 days of infection) highlight the urgent public health need to better understand and
characterize the potential association between COVID-19 and T2DM. Prior studies of PASC-associated T2DM
among adults living in the US have analyzed data from populations with limited racial/ethnic diversity, making
the results difficult to generalize to Black and Hispanic communities that experience disproportionately higher
rates of SARS-CoV-2 infection, COVID-19-related morbidity and mortality, and T2DM in the US. To advance
our understanding of T2DM risk after SARS-CoV-2 infection in racial and ethnic minority communities, we will
conduct a retrospective cohort study using the OneFlorida+ Data Trust, a Clinical Research Network (CRN)
within the National Patient-Centered Clinical Research Network (PCORnet) that contains patient-level
electronic health record (EHR) data for a diverse population of 19.2 million Americans seeking care in all major
metropolitan regions in Florida (the state with the 3rd highest number of COVID cases in the US) as well as
Atlanta, GA and Birmingham, AL. The association between SARS-CoV-2 infection and incident T2DM has yet
to be empirically quantified by race and/or ethnicity using rigorous methods and relevant variables (social
vulnerability and individual susceptibility factors) for diverse populations, despite the markedly higher rates of
COVID-19 and T2DM in minority communities. We will employ a rigorous analytic approach that utilizes high-
quality data available for both individual susceptibility and social vulnerability factors in the OneFlorida+ Data
Trust, a dataset that includes large proportions of minority groups (24% Hispanic, 18% Black), to address this
critical gap in knowledge. In addition to standard EHR data such as diagnosis/procedure codes, laboratory
values, medications, patient demographics, and vital signs, the OneFlorida+ Data Trust includes linkages to
exposome data on the natural, built, and social environments. Additional strengths of the OneFlorida+ Data
Trust for this project include availability of validated computable phenotypes (CPs) for diabetes to reduce the
chance of outcome misclassification; differentiation of healthcare encounter types; larger proportions of young
adults and women than prior studies of PASC-associated T2DM; diverse payer sources; and the capacity to
link patient records across OneFlorida+ Data Trust contributing sites. Our specific aims are (1) to assess
racial/ethnic differences in PASC-associated T2DM incidence in a retrospective cohort using the OneFlorida+
Data Trust and (2) to compare changes in cardiometabolic risk factors following SARS-CoV-2 infection by
race/ethnicity in a retrospective cohort using the OneFlorida+ Data Trust. This study will fill critical knowledge
gaps in the potential association between COVID-19 and new-onset T2DM in racial and ethnic minority
communities. The findings will directly inform diabetes screening recommendations in the rapidly growing
population of patients experiencing PASC.

Public health relevance
PROJECT NARRATIVE The association between SARS-CoV-2 infection and incident T2DM has yet to be empirically quantified by race and/or ethnicity using rigorous methods and relevant variables for diverse populations, despite the markedly higher rates of COVID-19 and T2DM in minority communities. We will use a rigorous analytic approach that incorporates high-quality data which captures both individual susceptibility and social vulnerability in the OneFlorida+ Data Trust, a data source that includes large proportions of minority groups, to address this critical gap in knowledge. The findings from this study will directly inform recommendations for management of the rapidly growing population of patients experiencing PASC in terms of diabetes screening and cardiometabolic risk assessment in the months and years after SARS-CoV-2 infection.